PLASMAPHERESIS IN SERVERE LUPUS GLOMERULONEPHRITIS

This is a longitudinal follow-up study of a national collaborative trial examining the effects of plasmapheresis plus conventional therapy versus conventional therapy alone in patients with severe diffuse proliferate lupus glomerulonephritis.